Scaling-up flow processes for the chemoenzymatic synthesis of a sialylated glycan

Abstract -
Human milk oligosaccharides (HMOs) are abundant components of human milk that hold extraordinary potential
as novel formula supplements and therapeutic agents to improve gut inflammatory disorders, autoimmune and
allergic diseases. Originally considered prebiotics that help shape the gut microbiome of breastfed infants, some
HMOs are increasingly becoming known for their beneficial immunomodulatory and anti-inflammatory properties.
HMOs prevent pathogen attachment to infant mucosal surfaces to lower the risk of infections, modulate epithelial
and immune cell responses, reduce excessive mucosal leukocyte infiltration and activation, and lower the risk of
necrotizing enterocolitis. However, the inability to source pure, structurally defined complex HMOs in sufficient
quantities has hindered their systematic study and efforts to leverage the extraordinary biomedical potential of
these commercially relevant human milk bioactives. In response to the critical need to significantly improve the
production efficiency of HMOs, Zymtronix is applying its proprietary multienzyme immobilization technology to
produce most HMO milk constituents via cell-free biomanufacturing, thereby removing a major barrier to their
investigation in the infant and adult therapeutic space—a mission aligned with the Glycoscience NIH Common
Fund. In Phase I, Zymtronix demonstrated successful production of multiple HMOs. In this Phase II project,
Zymtronix proposes to significantly improve the production efficiency of human milk oligosaccharides (HMOs),
initially focusing on a sialylated HMO which has been demonstrated to be highly protective against necrotizing
enterocolitis (NEC) – a devastating inflammatory gastrointestinal disorder with a 10-50% mortality rate in
premature infants and total annual cost burdens upwards of $1B. To validate the quality and efficacy of this
compound in small and large animal models of NEC, Zymtronix is partnering with Drs. Lars Bode (UCSD) and
Doug Burrin (Baylor College of Medicine), world-class experts in HMOs, pediatric nutrition, and gastroenterology.
Phase II Aims are to optimize biocatalytic production (Aim 1), conduct a proof-of-concept study to replicate
efficacy study in rats (Aim 2), demonstrate a scalable production and purification method (Aim 3), and for the
first time, demonstrate the use of this sialylated HMO at multi-gram scale in piglets (Aim 4). The project will
establish a cost-effective and industrially scalable method of production that will put 100s grams quantities into
the hands of researchers and commercial partners who desire to systematically investigate its efficacy against
NEC with the long-term goal of substantially improving the outcome for neonates at risk of NEC. This HMO is
just one of several beneficial molecules that will be substantially more accessible as an outcome of the proposed
work, creating the ability to utilize these free glycans in a wide range of applications from nutrition to therapeutics.

Public health relevance
Narrative - Human milk oligosaccharides (HMOs), abundant components of human milk, hold extraordinary potential as biomedical and therapeutic agents to treat inflammatory, autoimmune, and allergic diseases, but the unavailability of methods to produce them in large quantities and affordable cost has hindered their systematic study and efforts to leverage their biomedical potential. To significantly improve HMO production efficiency, Zymtronix is applying its proprietary multienzyme immobilization and cell-free biocatalytic manufacturing systems to produce most HMO milk constituents and demonstrated successful production of multiple complex HMOs in Phase I. In this Phase II project, the company will focus on a single syalilated HMO that is more complex than any other previously synthesized using these methods which has been demonstrated to be highly protective against necrotizing enterocolitis (NEC) – a devastating inflammatory gastrointestinal disorder with a 10-50% mortality rate in premature infants and total annual cost burdens upwards of $1B.